Core--Molecular genetics

The Molecular Genetics Core Laboratory (MGCL) will provide an important resource to the TTURC based upon existing sample handling, biorepository and high throughput assay procedures. This core will be within Dr. Shields' Molecular Epidemiology Section the Laboratory of Human Carcinogenesis (LHC) within NCI. The MGCL is uniquely suited to provide the laboratory genetic support for existing hypotheses and to develop assays for new hypotheses. Our specific aims are: (1) to provide a certified Molecular Genetics Core Laboratory (MGCL) that ensures consistent and high quality sample handling, analysis and reporting for samples generated by the TTURC; (2) to provide sample receipt, sample processing and biorepository procedures for all TTURC samples; (3) to provide existing consistent methods for DNA extraction and genetic polymorphism analysis; and (4) to provide accurate reporting, quality control and quality assurance procedures. The MGCL will maintain CLIA certification for quality control and quality assurance, among existing procedures for accurate determination of assay results and reporting. Performing large-scale molecular epidemiology studies require experience and expertise. Our laboratory has done DNA extractions. from blood (white blood cells, blood clots and serum), buccal swabs, oral rinses, frozen human organ tissue (lung, liver, colon. breast), urine and paraffin-embedded tissues. During the last five years, this constitutes DNA from more than 2,000 persons. Our success rates are greater than 98%. In calendar years 1996, 1997 and 1998, we performed 21 different genotyping assays for a total of 24,315 individual assays. There are different ways for laboratories to perform quality research. Ours is to maintain Clinical Laboratory Improvement Amendments (CLIA) certification. This is a government-mandated quality control and quality assurance monitoring program for clinical laboratories.